White Matter Injury and Repair in Vascular Cognitive Impairment and Dementia

Vascular cognitive impairment and dementia (VCID) is the second most common type of dementia. No protective
or disease-modifying strategies are available to reverse or halt VCID. A major feature of VCID is white matter
pathology, including demyelination and a loss of myelin producing cells, which are highly correlated with cognitive
deficits in the aged population. Oligodendrocyte precursor cell (OPC) differentiation occurs in white matter
enriched areas upon chronic hypoxia but is insufficient for white matter repair. Thus, a legitimate strategy to
improve functional outcomes in VCID is to enhance white matter integrity by protecting oligodendrocytes and by
promoting oligodendrocyte regeneration.
Adiponectin, the most abundant adipokine in the blood, plays a crucial role in CNS pathologies. We have reported
that adiponectin is important for cognitive function and reduces hippocampal neuronal loss in the asymmetric
common carotid artery stenosis (ACAS) mouse model of VCID. However, the effects of adiponectin on white
matter integrity after VCID are unknown. To fill this important gap, we recently evaluated the functional impact
of adiponectin on white matter components after ACAS in young mice. Our pilot data show that adiponectin
deficiency reduces white matter integrity and impairs axonal conduction 42d after ACAS. Adiponectin knockout
(KO) mice display greater oligodendrocyte loss and less oligodendrocyte regeneration. In contrast, treatment
with adipoRon, a small-molecule agonist of adiponectin receptors, improves long-term white matter integrity and
leads to superior cognitive functions up to 42d after ACAS. We observed that adiponectin receptor 1 (adipoR1)
is highly expressed on oligodendrocytes and microglia in vivo. In vitro data further suggest that adipoRon protects
cultured oligodendrocytes against oxygen/glucose deprivation through AMPK activation. AdipoRon also
enhances microglial phagocytosis and promotes the oligodendrogenic capacities of microglia.
Based on these promising data, we will test the new hypothesis that adiponectin promotes structural and
functional white matter integrity and improves neurological function in chronic cerebral hypoperfusion-
induced VCID by dual mechanisms: 1) enhancing oligodendrocyte survival through AMPK activation, and 2)
promoting a reparative microglial phenotype with high oligodendrogenic capacities. Three Specific Aims will
be tested. Aim 1: Test if adiponectin protects oligodendrocytes in an AMPK-dependent manner to improve white
matter integrity after ACAS. Aim 2: Test if adiponectin shifts microglia toward a reparative phenotype that
enhances OPC differentiation after ACAS. Aim 3: Test if adipoRon treatment enhances white matter integrity
and improves long-term cognitive functions after ACAS in aged mice of both sexes. These studies will shed light
on adiponectin as a key mediator to improve white matter integrity in VCID. Positive outcomes would also hasten
the development of adipoRon as a clinical treatment in elderly men and women with VCID.

Public health relevance
Vascular cognitive impairment and dementia (VCID) is a common type of dementia and mainly affects the elderly. White matter damage is frequently detected in aging brains as a prodromal sign of dementia, and therefore represents a legitimate therapeutic target. This study will elucidate the role of adiponectin, an adipocyte-derived cytokine, in promoting white matter integrity. We hypothesize that adiponectin protects oligodendrocytes and enhances reparative microglial responses. We will also test if treatment with adipoRon, a small molecule agonist of adiponectin receptors, enhances white matter integrity and improves long-term cognitive functions after VCID in aged mice of both sexes.